Hydrogen Sulfide for the Prevention of Cisplatin-Induced Atherosclerosis

Project Summary
Cisplatin (CDDP) is a widely used chemotherapeutic used to treat various cancers, including testicular, lung,
head and neck, and ovarian. CDDP use is associated with long-term cardiovascular morbidity and mortality risk,
including acute coronary syndrome (ACS). Patients treated with CDDP-based therapies have demonstrated a
higher prevalence of cardiovascular risk factors that contribute to the development of ACS. The induction of
oxidative stress and pro-inflammatory signaling are known contributing factors in other pathologies of CDDP-
induced toxicity. During atherosclerosis progression, pro-inflammatory activation promotes macrophage foam
cell death; expansion of the necrotic core, and deterioration of the fibrous cap, resulting in plaque destabilization
and coronary artery thrombosis. Hydrogen sulfide (H2S), a gasotransmitter, has gained therapeutic interest due
to its known ability to reduce oxidative stress and inflammation. However, H2S has not been studied for its
potential to treat CDDP-induced ACS, thus we will assess its protective effects against CDDP-induced plaque
instability in a model of atherosclerosis.
Based on my preliminary results, I hypothesize that CDDP-induced ROS and inflammation promote
macrophage foam cell necroptosis, which may be attenuated by H2S. Our preliminary data support that CDDP
induces macrophage foam cell death, which is attenuated by Nec-1, a necroptosis inhibitor, and GYY4137, an
H2S donor. We will first assess the activation of necroptosis in CDDP-treated macrophage foam cells by western
blot, ELISA, and siRNA knockdown of necroptotic mediators. Furthermore, we will evaluate the ability of H2S to
attenuate CDDP-induced cell death.
Second, we hypothesize that CDDP administration increases plaque vulnerability in vivo, which may be
attenuated with an orally administered H2S donor, SG1002. To test our hypothesis, we will use Ldlr knockout
mice placed on a high-fat diet as a model of atherosclerosis. A repeated low-dose model of CDDP toxicity will
be used (weekly i.p. injections, for 4 weeks). We will perform aortic dissections to conduct histological and
immunocytochemical analysis to assess plaque burden, necrotic core area, fibrous cap thickness, and
macrophage-to-smooth muscle ratio. We will then determine the impact of SG1002 administration on the effects
of CDDP on plaque vulnerability using the parameters mentioned previously.
Identifying the molecular mechanisms contributing to CDDP-induced foam cell death and plaque
instability will provide crucial insights into the link between CDDP-based regimens and ACS in cancer survivors.
Furthermore, this proposal will present a novel therapeutic approach to circumvent CDDP-induced ACS, which
can result in the clinical presentations of myocardial infarction in cancer survivors.

Public health relevance
Project Narrative Cisplatin is a commonly used chemotherapeutic whose use is associated with acute coronary syndrome (ACS) in cancer survivors. Our proposed study examines the molecular mechanism by which cisplatin induces foam cell death and its effects on plaque instability in vivo. Furthermore, we will assess the therapeutic potential of H2S against cisplatin-induced ACS, thus making strides to increase the quality of life and longevity of cancer survivors.